Arterial contractility and blood pressure regulation by statins

PROJECT SUMMARY: Statins are used by over 200 million people worldwide for treating atherosclerotic
cardiovascular diseases such as hypertension, coronary artery disease, and stroke. Pre-clinical and clinical data suggest
that statins produce blood pressure (BP)-lowering action in some subjects while having BP-neutral effects in others.
However, the underlying mechanism for such contrasting effects remains unclear. The conventional view is that long-term
statin therapy produces a range of beneficial vascular effects due to the inhibition of mevalonate/cholesterol biosynthesis
and Rho and Rho-associated protein kinase (ROCK) signaling in vascular smooth muscle cells (SMCs) and endothelial
cells (ECs). However, whether statins can directly act on a vascular target to regulate arterial contractility, independent of
the conventional pathways, and the pathophysiological significance of such a target of direct statin action remain unclear.
Due to the coexistence of hypertension and dyslipidemia and the use of statins by over 200 million people, it is critically
important to determine whether statins have inherent BP-lowering actions so that clinicians can tailor antihypertensive
therapy to the needs of individual patients. In this proposal, we aim to investigate the direct vascular effects of the three
most commonly used statins in resistance mesenteric arteries (RMAs) from wild-type and transgenic normotensive and
hypertensive animals to determine the mechanism of differential BP regulation by statins, both acutely and in the long-
term, and propose a framework for harnessing the BP-lowering actions of statins that may potentially benefit millions.
Based on our novel preliminary data, the central hypothesis of this proposal is that statins stimulate rapid RMA
vasodilation by selectively inhibiting phosphodiesterase 1A (PDE1A) in SMCs, thereby elevating [cGMP]i, leading to
protein kinase G (PKG) activation, vasodilation, and BP reduction, an effect that is abolished by endothelial dysfunction
that impairs upstream NO signaling into SMCs. In this proposal, we will to characterize the role of the NO-
PDE1A/cGMP-PKG signaling axis, which may shed light on the mechanisms behind BP-lowering and BP-neutral effects
of statins. Overall, this proposal could unveil novel cardiovascular targets and therapeutic applications of the world’s most
prescribed drugs in hypertension, and serve as the guide to clinicians to tailor antihypertensive therapy to the individual
needs of patients with coexisting hypertension and dyslipidemia.

Public health relevance
PROJECT NARRATIVE: Statins are used by over 200 million people in the world for the prevention and treatment of atherosclerotic cardiovascular diseases. Research over the past three decades suggest that statins produce blood pressure (BP)-lowering action in some subjects while having BP-neutral effects in others. However, the underlying mechanism for such contrasting effects remains unclear. In this proposal, we will investigate the direct vascular effects of the three most commonly used statins in resistance mesenteric arteries (RMAs) from wild-type and transgenic normotensive and hypertensive animals to determine the mechanism of such differential BP regulation by statins, both acutely and in the long-term, and propose a framework for harnessing the BP-lowering actions of statins. The central hypothesis of this proposal is that statins stimulate rapid RMA vasodilation by selectively inhibiting phosphodiesterase 1A (PDE1A) in SMCs, thereby elevating [cGMP]i, leading to protein kinase G (PKG) activation, vasodilation, and BP reduction, an effect that is abolished by endothelial dysfunction that impairs upstream NO signaling into SMCs. In this proposal, we aim to characterize the role of the NO-PDE1A/cGMP-PKG signaling axis, which will illuminate the mechanisms behind BP- lowering and BP-neutral effects of statins.